Planning & Evaluation Core

The Partnership for Native American Cancer Prevention’s (NACP) Planning and Evaluation Core (PEC)
serves each of the NACP components by ensuring that they demonstrate impactful progress toward the overall
goals within the 21-year Partnership between the Northern Arizona University (NAU) and the University of
Arizona Cancer Center (UACC). Moreover, during this new funding period, the PEC will expand on the
experience and relationships developed throughout the duration of NACP’s existence to incorporate
community priorities. This will be accomplished through a two-eyed seeing framework –leveraging Indigenous
and Western knowledge – the research projects will address cancer priorities of AIAN communities and tribes.
PEC interacts with five entities to provide expert, unbiased, rigorous evaluation of NACP progress and
recommend improvements and new directions as the NACP continues to evolve. These entities include:
NACP’s Executive Committee (EC) made up of the multiple Principal Investigators (MPIs), Core/Shared
Resource Co-Leaders, the Evaluator and Partnership Managers; the Internal Advisory Committee (IAC)
consisting of research and education leaders from both NAU and UA outside the direct responsibilities of
NACP; the Community Advisory Board (CAB), composed of community members that hold leadership
positions within tribes and/or are involved in cancer health-related tribal initiatives; the Program Steering
Committee (PSC), an external advisory board comprised of nationally-recognized experts in cancer research,
health disparities including Native American-specific cancer disparities, and training of biomedical researchers,
and the officers and leaders of the National Cancer Institute’s
Center to Reduce Cancer Health Disparities
(CRCHD) and its Comprehensive
Partnerships to Advance Cancer Health Equity (C
PACHE) program
.
Additionally, innovations this cycle include building Native American evaluation leadership, incorporation of the
two-eyed seeing framework in evaluation and community engagement, and enhanced cross-institution
matchmaking. With this expertise and novel approaches, PEC will address the following Specific Aims:
Aim 1. Maintain and expand a comprehensive evaluation feedback system to support data-
driven decision-making for program improvement and innovation.
Aim 2. Collaborate with five entities (EC, IAC, CAB, PSC, CRCHD/CPACHE) to engage in internal
and external planning and assessment of NACP’s activities and outcomes, with the goal of continual
improvement in the NACP’s ability to achieve its overall goals.
Aim 3. Direct the solicitation, development, and selection of new cancer health disparity
focused research projects that are responsive to the needs and priorities of Native American
communities, as well as monitor the scientific progress and productivity of active research projects.